2023 Collagen Gordon Research Conference and Seminar

Project Summary
Collagens are large molecules that typically form molecular aggregates in the extracellular matrix (ECM).
There are 28 distinct collagens in vertebrates, all composed of 3 collagen chains that fold into one or more
characteristic triple helical domain. Some collagens are homotrimers formed of three identical chains and
others are heterotrimers formed of two or three distinct gene products: hence, 46 genes code for the collagens
in humans. In addition, several other molecules contain collagenous domains. Pathogenesis can result from
either insufficient amount or the presence of mutant forms of the protein and can affect virtually all tissues
and organs. Tissue fragility, often a sign of collagen dysfunction, and fibrotic processes, that is accumulation
of collagen, are classical examples of how collagen defects or dysregulation affect health and disease.
Collagens are traditionally recognized for providing structural support for tissues. It is now clear that they
have other important biological functions that are executed by the parent molecule or by subdomains that are
proteolytically released and endowed with novel bioactive properties. These variable, yet critical, functions
include roles in controlling angiogenesis, stem cell niches, and malignant growth. Collagen function can also
be variably tuned through unusually complex posttranslational modifications, exemplified by 4-hydroxylation
of proline residues. Interestingly, mechanistically similar enzymes are used to regulate the body´s hypoxia
response, a finding awarded by the 2019 Nobel Prize in Medicine and Physiology.
The 2023 meeting will mark over 50 years of the Collagen GRCs, an uninterrupted series starting in 1970,
and since 2013 expanded to include a GRS targeting ECRs. The central goal is to understand how collagens
interact with other ECM molecules and cells in physiological contexts, and what are the molecular
consequences of collagen mutations with respect to these complex interactions and dependencies.
Importantly, we will link collagen research to a broader context of biology, as exemplified by the recent
understanding that can now be used to develop drugs that target the hypoxia inducible factor (HIF) prolyl-
hydroxylases for the treatment of, e.g., chronic kidney disorders and cancer. Other fields growing in impact
that will be highlighted pertain to biomechanical and bioengineering aspects, stem cell guidance, fibrosis,
malignant growth, and musculoskeletal development and pathology. The session on big data in collagen
research aim to bring forward the rapidly increasing systems biology approach regarding the association and
roles of collagens in normal and disease situations. Moreover, we aim to highlight novel data on the transport
and homeostasis of collagens in tissues and cells. The meeting will also provide a unique opportunity to
discuss how the rapidly expanding field will look in 5-10 years and what is needed for the field to advance.
The break of 4 years induced by the Covid 19 pandemic further highlights the importance of the 2023
conference and seminar both for established scientists and especially the early career researchers.

Public health relevance
Project Narrative Collagens form the most abundant protein component of the human body, providing tissues and organs resilience and structure, as well as participating in regulation of cellular function. The collagen genes can be mutated leading to a wide spectrum of genetic and fibrotic disorders. The 2023 Collagen Gordon Conference and accompanying Seminar represent frontier science in the rapidly advancing field of collagen research, with topics ranging from molecular properties of collagens to understanding of their complex physiological and pathological roles as key components of the extracellular milieu, and links to other biological processes such as adaptation to oxygen availability.